Improving Psychological Outcomes for Acute Respiratory Failure Survivors using a Self-Management Intervention

Project Summary (from parent award)
An increasing number of adults in the U.S. develop acute respiratory failure (ARF) requiring mechanical
ventilation in an intensive care unit (ICU). To improve patient outcomes, evidence-based guidelines
recommend titrating sedatives to allow for patient wakefulness while in the ICU. However, among awake ARF
patients, anxiety can be a common and long-lasting problem. Outside of the ICU setting, self-management
interventions are established, evidence-based, first-line treatments for patients with anxiety. However, there is
limited evidence about the feasibility and benefit of self-management interventions for ARF patients during
hospitalization. Hence, this K23 proposal seeks to: 1) conduct a qualitative study in hospitalized patients to
refine an existing Self-Management in Acute Respiratory Failure (SMARF) intervention (Aim 1), and 2) conduct
a pilot randomized controlled trial (RCT) of the refined SMARF intervention vs. usual care in the ICU and wards
to establish its feasibility, acceptability (primary outcome; Aim 2a), and potential efficacy in reducing anxiety
symptoms and associated outcomes at hospital discharge (Aim 2b) and at 3-month follow-up (secondary
outcomes; Aim 3).
Megan Hosey, PhD, a practicing clinical psychologist and Assistant Professor at the Johns Hopkins
School of Medicine, has a long-term career goal of becoming an independent, patient-oriented researcher in
acute respiratory failure, examining early interventions to reduce psychological symptoms and improve long-
term functional outcomes. Through this K23 award, Dr. Hosey will achieve the following career goals: 1) gain
expertise in qualitative research via didactic coursework and mentored practical experience, 2) deepen
knowledge and experience in patient-oriented research by completing a Master of Health Science (MHS)
degree in Clinical Investigation and conducting a pilot RCT, and 3) gain mentored experience with scientific
publication and grant writing. This award will result in preliminary data and skills that will lay the foundation for
a successful future R-level grant and pathway towards independent investigator status. This award will build
upon Dr. Hosey’s extensive clinical expertise in self-management interventions for ARF patients and her
research background in the psychosocial aspects of recovery from ARF via providing tailored didactic training
and mentored research experience with a world-class team, all occurring in a resource-rich academic
environment.

Public health relevance
PROJECT NARRATIVE (from parent award) A growing number of patients are surviving Acute Respiratory Failure (ARF), but may experience long-lasting psychological problems after returning home. Early, evidenced-based treatment to reduce psychological symptoms in the intensive care unit and hospital may help improve patient outcomes, but research evaluating such treatment for ARF patients is scant. This project includes qualitative research that tailors an existing psychological intervention for use in ARF patients, then subsequently conducts a pilot randomized controlled trial to evaluate the feasibility, acceptability, and potential benefit of the psychological intervention on ARF patients’ anxiety and associated outcomes at hospital discharge and 3-month follow-up.